Translational Training in Addiction

PROJECT SUMMARY/ABSTRACT
This proposal seeks competitive renewal (years 11-15) of the UAMS NIDA T32 training program “Translational
Training in Addiction”. Spanning five academic departments and three Colleges, the program provides multi-
level, cross-disciplinary, team science training that spans the full translational research gamut from molecular
to population-based approaches to solutions to curb or halt drug addiction. With program priorities of training
innovation, diversity, connectivity and outcomes, this renewal request seeks to further the development of a
program of training excellence that is dynamic and evolving in response to the rapidly changing societal,
legislative, research, clinical and community responses to addiction. Quantitative and qualitative data support
the claim of program excellence for the current funding cycle. A program evaluation plan is based on progress
towards seven training objectives including (1) foster a shared knowledge of the broad societal and health
impacts of drug use disorders and of the diversity of engaged scientific disciplines, (2) provide an individualized
path to diverse addiction impact career areas and maximize post-training outcomes, (3) foster diversity as a
strength for maximizing program impact, (4) provide career building environments emphasizing
interdisciplinary, team science, translational research, (5) innovate advances in training approaches to
research ethics, professional development, and program connectivity, (6) evaluate both bibliometric and
translational science benefit outcomes of the program, and (7) foster the engagement of physicians and other
clinicians in the career building processes of the program. Program administration, connectivity and oversight
would remain the roles of the program Director, co-Associate Directors, Governance and Steering Committees,
and external evaluators/advisers. Continued support is requested for three levels of trainees involving three
predoctoral students, four postdoctoral fellows, and four annual M2 summer addiction research interns,
complemented by institutional support of one annual PGY3 psychiatry resident, to foster the addiction
translational science training objective of the program. Program-wide courses, faculty-facilitated seminar and
presentation series, professional development lectures and workshops, and elective mentored research
training emphasis/impact areas would support translational research training opportunities across the full
spectrum of T0 to T4 translational science. Mechanisms of trainee and program evaluation focus on both
scientific bibliometric and translational human health and society benefit indicators of program impact.
Significant institutional commitment and resources support the accrued value and continued success of the
training program. A continued trainee-led program of community outreach would support a program goal of
bringing addiction science and impact into the community. The UAMS T32 training program has established a
cross-discipline network of connectivity between addiction researchers and clinicians that were previously
unlinked to contribute to the building of a translational science workforce.

Public health relevance
PROJECT NARRATIVE The current and future success of science in solving the drug addiction problem is dependent on broad partnerships between diverse researchers, clinicians, and affected communities that deliver discovery to addiction prevention and clinical care. Attaining this goal is increasingly best attributed to interdisciplinary, team-based, clinical translational research and the ultimate objective of this training program is to develop this next generation of addiction investigators. As the sole NIDA T32 training program at the only academic medical center in the state of Arkansas, the proposed program seeks to meaningfully impact the immense public health problem of drug addiction at both the national, regional, and state levels.